Carbon nanotube integrated microdevice for next generation sequencing based virus discovery

PROJECT SUMMARY
Infectious diseases account for one quarter of global deaths and massive economic loss. Pathogen discovery
is critical in combating infectious diseases. However, the causative agents in a large percentage of clinical
infectious disease cases remain unidentified. Often occurring in resource-limited areas, major outbreaks were
caused by newly emerging viruses, mostly wildlife-originated. The pressing challenges in viral infectious
diseases call for a sample-to-answer virus discovery platform that can prepare viral samples from
environmental and clinical samples for high throughput sequencing based virus discovery. In this proposed
research, we will develop a new carbon nanotube 3D sample preparation and enrichment microdevice (CNT-
3D-SPEM) that employs engineered carbon nanotube material, as shown in our preliminary study, into a new
continuous flow microfluidic design for virus particle enrichment. The new microfluidic design has a unique self-
regulating flow mechanism to achieve high virus capture efficiency and high sample capacity and flow rate
simultaneously. After enrichment, the captured viruses are lyzed inside the CNT-3D-SPEM. The viral genome
will be purified and amplified in situ, which are required sample preparation steps for virus discovery through
high throughput sequencing. Working with co-investigators together, we will conduct multiple pilot studies that
use the developed technology for virus discovery from clinical and environmental samples. The ultimate goal is
to develop the entire high-performance portable platform to advance virus discovery for the battle with viral
infectious diseases.

Public health relevance
PROJECT NARRATIVE A nanomaterial-integrated microdevice will be developed as a portable sample-to-answer platform for viral discovery. The device can rapidly enrich virus with high efficiency, then purify and amplify virus genome inside the device. Coupled with portable high throughput sequencer, the technology can advance virus discovery from environmental and clinical samples.